Kaiser Permanente NCI National Community Oncology Research Program, NCORP

ASTRACT
The Kaiser Permanente (KP) NCORP Community Site is committed to the principle that including community
providers and a diverse patient population is essential to advancing oncology research. The KP NCORP
Community Site has decades of experience conducting cancer clinical trial, care delivery, and disparities
research. During the first funding cycle, the KP NCORP Community Site brought the benefits of our racially
and ethnically diverse membership, increased access/accrual to clinical trials, and conducted cancer care
delivery research. The KP NCORP Community Site was exceptionally successful with both total and specific
trial enrollment to studies with our affiliated research bases. In 2017, for example, the KP NCORP Community
Site was the second-highest enrolling member of SWOG for total accrual and the highest for CTEP-funded,
SWOG-credited trials. In addition, KP NCORP Community Site clinicians and population scientists served on
numerous NCI and Research Base Steering, Scientific, and Working Group Committees, making important
contributions to the NCORP research agenda. In the next funding cycle, we will continue to participate in this
integrated national network of community organizations to increase the involvement of community oncologists,
other medical specialists, and our patients. Continued participation in multi-institutional cancer control,
prevention, and care delivery research, as well as quality-of-life studies embedded within treatment and
imaging studies conducted under the NCORP and NCTN, will benefit the community at large. Our clinician and
population scientists will continue to serve on NCI and Research Base committees and provide insight into
clinical significance, identifying care disparities, and provide input on feasibility during protocol development.
We will continue to recruit patients, including enrolling participants from underrepresented populations.

Public health relevance
NARRATIVE As a member of NCORP’s integrated network of community organizations and research bases, the Kaiser Permanente (KP) NCORP Community Site will bring medical advances to the community at large by increasing clinical trial access and accrual to cancer control, prevention, symptom management, imaging, treatment, and cancer care delivery research. KP’s integrated health plan presents an ideal platform for accelerating the translation of findings into clinical practice.